ISOTOPE DILUTION MASS SPECTROMETRIC QUANTIIFCATION OF 3 NITROTYROSEINE

Oxidative damage by reactive nitrogen species has been implicated in the pathogenesis of atherosclerosis and other inflammatory diseases. The mechanims of tissue damage are poorly understoond, however, because the toxic intermediates are short-lived. Previous in vitro studies have suggested that 3-nitrotyrosine represents a specific marker of protein oxidation by reactive nitrogen species. The detection of this nitrated aromatic amino acid may thus serve as an indciator of tissue injury by nitrogen species in vivo. Here we describe a highly sensitive ans specific analytical method for quantifying free and protein-bound 3-nitrotyrosine. The assay involves acid hydrolysis of proteins, isolation of 3-nitrotyrosine by ion exchange chromatography, and reduction of 3-nitrotyrosine to 3-aminotyrosine with dithionite. The reduced amino acid is then converted to its n-propyl, per-heptafluorobutyryl derivative and quanitfied by isotope dilution gas chromagtography negative-io n chemical ionization mass spectrometry. Attomole levels of 3-nitrotyrosine can be reproducibly measured in this manner. Quantifying 3-nitrotyrosine levels of tissues by stable isotope dilution gas chromtogrpahy/mass spectrometry should provide a powerful tool for exploriong the impact of reactive nitrogen species on oxidative readtions in vivo.